Word Learning and Vocabulary Development in Blind Children

Project Summary
A lack of visual experience may affect language development in the domains of word learning and vocabulary
development in ways that necessitate specific instructional approaches and interventions for blind children.
Compared to sighted children, blind children may learn more words from the auditory modality (i.e., speech)
because they do not casually perceive writing in their environment and often experience reading delays. They
may also learn fewer words from direct perceptual experience because they cannot acquire the meanings of
words by perceiving their referents visually. Cumulatively, these word learning differences may affect the tra-
jectory of vocabulary development in early and middle childhood. An improved understanding of vocabulary
development could improve education for this underserved population. Unfortunately, word learning and vo-
cabulary are understudied within the area of blind children’s language development. This observational analytic
study employing a cross-sectional design directly compares self-reported modes (perceptual or linguistic) and
channels (spoken or written) of word learning for individual words in blind and sighted children. It also com-
pares their trajectories of vocabulary development from age 5 to 12. Specific aims are 1) Determine whether
vocabulary development in blind children is delayed relative to sighted children; 2) Examine whether
mode and channel of word learning in blind children differ from those in sighted children; and 3) Present a
dataset of age-of-acquisition, mode-of-acquisition, and channel-of-acquisition norms for future use in
research. The approach is innovative because objective age-of-acquisition norms (obtained from children
themselves rather than subjective adult estimates) are by definition more reliable and valid than subjective
norms and are exceptionally rare, even for sighted populations. The verbal administration of tasks that are typi-
cally administered visually will make them accessible not only to blind children, but to any child with a reading
or learning disability. Finally, the virtual approach to data collection will allow the researchers to reach more
individuals from a population that is historically difficult to study. The project is an instrumental part of the PI’s
long-term goal of understanding how vocabulary develops without sight and applying this understanding to im-
prove educational strategies and outcomes in blind children.

Public health relevance
Project Narrative This project examines how school-age blind children acquire word meanings, and whether the trajectory of vocabulary development in blind children is altered or delayed relative to that in typically sighted children. Findings from this research have the potential to improve instructional approaches and language and literacy interventions for blind children.